MAPPIING OF THE CEREBRAL CORTICAL AREAS USING FMR1

The purpose of this study is to determine whether functional magnetic resonance imaging (fMRI) can determine which areas of the brain sense distention of the esophagus, stomach and rectum.